A 90 day, Phase 3, Open Labeled Exploratory Study of RELiZORB to Evaluate Safety, Tolerability, and Nutrient Absorption in Children with Short Bowel Syndrome who are Dependent on Parenteral Nutrition

Project Summary/Abstract
Short bowel syndrome (SBS) is often due to the loss of large amounts of small intestine that compromises
digestive absorption. The treatments include a high-calorie diet and feeding through the vein (i.e., parenteral
nutrition or PN), among others. Many patients cannot wean from PN due to reduced intestinal length or function.
Patients on long-term PN frequently experience serious metabolic complications, sepsis, hepatic biliary disorders
including cholestasis, and fibrosis and can progress to liver failure. Full intestinal feeding (enteral nutrition)
without PN is the optimal way to prevent the above complications.
Enterally administered long chain triglycerides in patients with SBS, especially those with hepatic
dysfunction, are not well tolerated due to bile acid malabsorption, which leads to decreased micelle formation
and fat digestion. The dietary fat is unable to be emulsified by the bile acids and acted on by lipases before
exiting the patient as stool. Switching to other forms of fat such as medium-chain triglycerides (MCTs) that do
not require micelles for absorption may be better tolerated in patients with bile acid or pancreatic insufficiency
but are not optimal as they increase the osmotic load in the intestine. This may increase the chance of stool
dumping; moreover, MCTs do not contain essential fatty acids (FAs). The ability to provide the essential FAs
such as those present in enteral formulas in a form that does not require the formation of micelles for absorption,
would allow patients with SBS and those who are no longer PN dependent to receive adequate nutrition and
continue to maintain the same growth trajectory as when they received the majority of their nutrition parenterally.
RELiZORB is an enzyme cartridge connected in-line with enteral feed tubing sets designed to mimic the
function of pancreatic lipase. It is hypothesized that by using this external lipase device, enteral nutrition will be
better absorbed, and PN dependence reduced as enteral autonomy is increased. This product eliminates the
need for intestinal emulsification and eliminates the risk of drugs, including lipases, allowing absorption at the
time the diet enters the gut. The device has been shown to digest >90% of fat in most enteral formulas.
This is a phase 3, open label single center clinical trial to determine the safety, tolerability, and
bioavailability of the RELiZORB enzyme cartridge with enteral nutrition when used daily for 90 days in pediatric
subjects with SBS, aged 2 years – 18 years, who are PN dependent. The change in PN calories from baseline,
assessed weekly, will be evaluated by area under the curve as a mean percentage increase or decrease and
presented with a 95% confidence interval. The number (percent) of treatment-emergent adverse events, grade
2 or above, as well as the incidence of abnormalities in vital signs, changes in stool amount/frequency, ostomy
output, the need to decrease enteral feeds, changes in urine color, hematology and biochemistry parameters will
be tabulated. Changes in growth z-scores, 72-hour fecal fat and coefficient of fat absorption, plasma FAs, PN
volume, enteral/oral nutrition, and ability to wean from PN will also be described.

Public health relevance
Project Narrative Children with inadequate intestinal absorption due to loss of large amounts of small bowel require intravenous nutrition (feeding through the vein) to sustain hydration and nutrition to avoid starvation and dehydration; however, intravenous (IV) nutrition can lead to complications including liver failure. Tube feeding directly to the small intestine avoids the complications of IV nutrition, but fats are not fully digestible due to inadequate bowel function. We propose to predigest the fat using a small cartridge attached to the feeding tube to allow for rapid absorption with the possibility of reducing or eliminating the need for intravenous nutrition.